2022 Lysosomes & Endocytosis Gordon Research Conference and Gordon Research Seminar

Abstract
This application requests partial support for a Gordon Research Conference (GRC) on Lysosomes and
Endocytosis at Proctor Academy, Andover, NH from June 19-24, 2022. Support for the associated Gordon
Research Seminar (GRS) immediately preceding the GRC (June 18-19) is also requested. The Lysosomes
and Endocytosis GRC has a 50+ year tradition as the preeminent scientific venue for investigators of
endocytosis and lysosome biology in health and in disease. It is also highly regarded for the high level of
communication between colleagues at all career levels, and for the mentorship of junior colleagues. For more
than a decade now molecular mechanisms of endocytosis and for targeting of molecules to the lysosome for
degradation have been the focus of this GRC. However, the field evolves rapidly, and recent advances indicate
roles for the endo-lysosome and autophagy pathways in cancer, development, cytokinesis, intra- and inter-
cellular signaling, immunity, metabolism, neurodegeneration and other neuronal diseases. The principal goal of
the 2022 GRC is to build bridges between investigators working to elucidate molecular mechanisms and
investigators of physiological aspects of the lysosome. A related goal is to raise awareness of and interest in
lysosome biology outside of the field proper. Accordingly, the 2022 GRC program will embrace an
exceptionally diverse cast of 28 invited speakers, favoring colleagues who have either not previously attended
or presented at this GRC. Also featured are investigators who have not attended the conference for many
years (e.g., >10 years) due to the evolving emphasis of their research programs on human disease; they
provide a reservoir of experience regarding the application of fundamental knowledge of the endo-lysosome
system to physiological questions. Areas to be addressed include the roles of the endo-lysosomal system in
cancer, pathogen (including viruses) infection, nutrient sensing, the control of metabolism, and signaling
between tissues. To attain the freshest program possible, nineteen speakers will be selected from submitted
abstracts and one entire session will be devoted to new research directions. All attendees will be encouraged
to participate in one of two poster sessions. A Gordon Research Seminar (GRS), open solely to graduate
students and postdoctoral researchers, will convene one day prior to the start of the GRC. The informal
atmosphere of the GRS allows trainees to build presentation and networking skills in a nurturing environment.
Due to the vital importance of the endo-lysosomal system to human physiology, and the exceptional record of
success of past Lysosomes and Endocytosis Gordon Research Conferences, the support of the NCI, NCATS,
NIAID, NIA, NICHD, as well as other NIH institutes, will advance critical investments toward understanding
lysosome biology in health and disease.

Public health relevance
Narrative The lysosome is a compartment within the cell where un-needed and damaged macromolecules are degraded and then supplied to the cell for re-use. Lysosome function protects the cell from the toxic effects accumulated defective molecules within the cell, eventually causing cell death, and loss of lysosome function results in a wide variety of diseases, including Parkinson's disease, cancer, bleeding and immune disorders, and many others. The Lysosomes and Endocytosis Gordon Conference and Seminar brings together scientists to discuss and debate the latest research regarding the formation and functions of the lysosome.